Genetic and Environmental basis of Cancer Risk and Disparities (GECaRD)

Abstract
This proposal is for a new T32 predoctoral program to train the next generation of multi-disciplinary cancer
researchers with the expertise to unravel the complexity of factors underlying cancer risk and disparities. The
rationale for this T32 is to bridge the gaps between cancer research fields with integrative education and holistic
professional development. The T32 leverages strengths of Stanford University and the Silicon Valley to provide
specialized cancer-focused training across traditionally distinct fields. The program blends in a highly interactive
fashion training opportunities in coursework, seminars, internships at Stanford University and local biotech
companies, and mentored research projects. Coursework and seminars include core offerings newly developed
for this program. Trainees will learn the methods and technologies used in foundational disciplines of cancer
research: epidemiology, biostatistics, genetics, omics, environmental health, health disparities, and community-
engaged research. The program will also train students with the concept of “cells to society,” the complex
interplay between biological, social, and environmental factors that shape health outcomes at both the micro and
macro levels. This approach recognizes that health is not solely determined by genetics or individual behaviors
but is also influenced by the social and environmental contexts in which individuals live, work, and interact. The
T32 is designed to train students in diverse skill sets, such as novel research methods, data analytics, as well
as soft skills like communication, teamwork, and leadership. This framework provides rigorous training, which
will be underpinned by the principles of responsible research conduct. Drs. John Witte and Melissa Bondy lead
the program having overseen multiple previous training programs and with decades of successful experience
training the future generation of cancer researchers. The T32 mentoring team is comprised of 26 outstanding
faculty members with cancer-focused research projects across multi-disciplinary fields. The program has
extensive financial and administrative support for trainees from Stanford University and the Stanford Cancer
Institute, rigorous student advising, and 360-degree evaluation among the trainees, mentors, an internal
executive committee, and an external advisory committee. By integrating multi-disciplinary approaches, the T32
has a strong foundation in which trainees develop the skills vital for furthering their careers in research to
decipher the causes of cancer and underlying disparities, ultimately providing valuable knowledge regarding the
prevention and equitable treatment of this common, but complex disease.

Public health relevance
Project Narrative Furthering the ongoing fight against cancer requires scientists who can communicate across traditionally distinct research disciplines such as epidemiology, biostatistics, genetics, -omics, and environmental health— while ensuring that advances are undertaken in an appropriate manner toward reducing disparities. The proposed T32 program will fulfill this need by providing exceptional training to prepare predoctoral students in the integration of innovative methods and cancer research questions in a cross-cutting transdisciplinary and translational manner. Graduates of the program will have the expertise to work in multidisciplinary teams and be tomorrow’s cancer research leaders.